A chemical biology-based approach to the study of FOXP3 and Regulatory T Cell Fate

ABSTRACT
Pharmacological modulation of regulatory T cell numbers and function has significant potential in the context of
autoimmune and inflammatory disease. However, the overlapping and pleotropic nature of immune-related
signaling pathways associated with currently known methods to expand functional regulatory T cells makes it
challenging to increase regulatory T cell populations, without having intolerable immunosuppressive or cytotoxic
effects. Agents reported to date can result in the expansion of additional cell types that can hinder the effect of
Tregs or produce nonfunctional Tregs. Here, we have conducted a high throughput flow cytometry screen to
address this issue and have identified multiple Treg-inducing small molecules, including A205804, as novel
inducers of FOXP3 expression. A205804 induces FOXP3 expression in human and mouse CD4+ T cells and
Tregs induced to differentiate using this compound maintain suppressive activity. Mechanistic studies revealed
that A204804’s ability to regulate Treg differentiation occurs independently of its reported impact on endothelial
cells (i.e., functional inhibition of ICAM-1 expression) or NF-kB signaling and also functions independent of
known mechanisms related to IL-2 or TGF- signaling. To achieve the overall objective of this proposal, the
following three specific aims will be successfully completed: 1A. Identify the relevant biomolecular target and
associated mechanism of action for A205804 in the context of its ability to induce functional human and mouse
CD4 Treg differentiation. 1B. Optimize the pharmacokinetic properties of A205804. 2A. Determine selectivity,
human activity and validate induction of suppressive Treg function for three novel mechanism of action small
molecule scaffolds (SR0723, SR0767, SR0320). 2B. Determine potential cross-reactivity with identified target of
A205804 and identify relevant biomolecular target(s) for small molecules demonstrated to function
independently of the A205804 mechanism. 3. Determine the ability of A205804 and at least one novel MOA
compound to selectively induce CD4 Treg differentiation, impact total CD4 Treg numbers and positively impact
remyelination in the cuprizone demyelination/remyelination model. Successful completion of the research
objectives described in this proposal will address a key knowledge gap in our understanding of the biology and
application of naïve CD4 progenitor T cells, which is relevant to human biology and diverse human disease
contexts. Specifically, by identifying actionable targets for the selective induction of Treg differentiation, results
from the proposed research activities will facilitate future preclinical studies and efforts aimed at developing stem
cell-based therapies with applications across diverse forms of inflammatory and auto-immune related human
diseases.

Public health relevance
Project Narrative Pharmacological modulation of regulatory T cell numbers and function has significant potential in the context of autoimmune and inflammatory disease. The objective of this project is to elucidate the mechanisms of action of novel small molecules that induce CD4 FOXP3+ Treg differentiation in vivo, in relevant rodent models.